Acquisition of an Oxford Nanopore sequencer for genomic analysis of a subterrestrial nematode

Abstract
The supplemental funding will allow the purchase of an Oxford Nanopore sequencer to enable
the Bracht laboratory to complete the aims of the parent award. The sequencing technology is
critical given that 45 separate RNA samples must be sequenced and outsourcing the work is
costly in both time and money. The Nanopore technology provides long, highly accurate reads
enabling many exciting applications both for the parent award and beyond. The supplemental
funding would provide a transformative technology, given there is currently no genomic
sequencers available at American University; furthermore, there is no Nanopore technology
available in the entire DC metro region containing at least five additional research universities
beyond AU. This supplement would therefore fill a regional gap in technological availability,
benefitting multiple universities and empowering the unique research conducted at American
University: highly interdisciplinary, undergraduate-engaged and with a high engagement of
under-represented students. Students and faculty alike would greatly benefit from the availability
of a transformative Nanopore sequencer at AU.
1

Public health relevance
This proposal explores the unique evolutionary adaptation of a nematode (roundworm) isolated from deep underground in a South African goldmine, whose genome has adapted to enable it to survive environmental stress. The pathway involved, the unfolded protein response (UPR), is also involved in human pathologies including neurodegeneration, cancer, and autoimmune disease. Thus, understanding the principles of adaptation in this organism may suggest new ways of treating these human diseases.